Oregon State Public Health Laboratory Participation in the FDA NARMS Retail Meat Program

Abstract
The Oregon State Public Health Laboratory (OSPHL) has participated in the National
Antimicrobial Resistance Monitoring (NARMS) Retail Meat Program since its inception
in 2002. OSPHL will continue to isolate and identify selected bacterial pathogens from
retail meat for active surveillance of foodborne illness. This work will generate isolates
and data to support epidemiological investigations and responses both locally and
nationally. The mission of the OSPHL is to protect the health and safety of Oregonians.
Participation in the NARMS Retail Meat Program furthers the OSPHL’s mission with
monitoring of pathogens in the food supply and identification of emerging public health
threats.

Public health relevance
Narrative The OSPHL participates in the FDA’s National Antimicrobial Resistance Monitoring System Retail Meat Program to monitor pathogens and the food supply and identify emerging public health threats. This study funds the lab’s collection and analysis activities, to provide data to state and federal epidemiologists for foodborne illness investigation and response.